Support of Diversity Initiatives in the UCSF-Bay Area CFAR: Developing HIV Researchers from Pipeline to Early Career Faculty (Revision to Developmental Core)

Project Summary/Abstract - Core
Please refer to the Overall section.

Public health relevance
Project Narrative - Core Please refer to the Overall section.